TME Administrative Core

Project Summary/Abstract – TME Administrative Core
The overarching objective of the Administrative Core of the Tumor Microenvironment Center of Biomedical
Research Excellence (TME CoBRE) is to create a scientifically rigorous and well-supported environment in which
PLs will gain independence. Subsequently, their collective success will propel the TME CoBRE to national
recognition and the mature teams toward program project type initiatives for further growth and sustainability.
The Administrative Core has six Aims that will allow us to achieve our objective. Specific Aim 1: Maintain a
rigorous, transparent, and scientific culture in the Tumor Microenvironment (TME) CoBRE. Specific Aim 2:
Maintain an effective administrative structure that will propel the TME CoBRE to national recognition. Specific
Aim 3: Maintain a structure for efficient fiscal responsibility and oversight. Specific Aim 4: Maintain and oversee
a highly enriched mentoring environment that will help the PLs in their scientific, career, and personal
development. Specific Aim 5. Continue the pilot project program during Phase II to recruit new PLs to the TME
CoBRE. Specific Aim 6. Use both formative and summative evaluations to measure progress toward critical
benchmarks. For all Aims, there are well defined measurable objectives, outcomes, or processes. Interwoven
through numerous Aims is a strong mentoring process and a rich scientific environment. Importantly, the TME
CoBRE will synergize with established IDeA initiatives across the state, including the West Virginia Clinical and
Translational Science Institute, an INBRE as well as the WVU Vision Sciences CoBRE and WVU Stroke
CoBREs.